Molecular mechanisms controlling secretion in filarial nematode parasites

Project Summary
Parasitic nematodes infect over 1.5 billion humans. Control of this poverty-associated global health burden relies
almost entirely on the administration of a small number of anthelmintic drugs. The prospects of anthelmintic
resistance and the sub-optimal nature of these drugs in many nematode parasites demand new approaches to
parasite treatment and control. However, the need to develop new antiparasitic treatment options is hampered
by large gaps in our basic knowledge of the nematode biological processes that promote the establishment and
maintenance of infection. Excretory-secretory (ES) products released by parasitic nematodes into their host
environments are essential for host immune modulation and successful parasitism. Despite the general under-
standing that the ES system is a conduit for the release of molecules (proteins and vesicles) that promote parasite
survival, we have a poor understanding of the underlying structure and function of the ES apparatus in medically
important parasitic nematodes. To address this gap in knowledge, this project will identify regulators of secretory
function in Brugia malayi, a mosquito-transmitted ﬁlarial nematode and causative agent of human lymphatic ﬁlar-
iasis (LF). Recent studies in B. malayi, including on the mode of action of ivermectin, support the premise that
the ES apparatus is a lucrative and unexploited source of new therapeutic targets. Our overarching hypothesis
is that cell-surface receptors localized to the B. malayi ES system directly or indirectly control parasite secretory
function, and that they can be targeted to interfere with the release of ES-derived molecules. We will pursue
three aims, motivated by preliminary receptor leads and made feasible by innovative methods we have optimized
to resolve the transcriptomic state of the B.malayi ES system and to proﬁle receptors implicated in parasite se-
cretory function. We focus our efforts on G protein-coupled receptors (GPCRs), which are proliﬁc drug targets
and known to be expressed in nematode ES cells and adjacent cell types that may act on the ES system. In
Aim 1, we will use innovative spatial transcriptomics approaches to resolve the transcriptome of the B. malayi
ES region across intra-host stages and to identify candidate GPCRs that regulate ES function. In Aim 2, we will
use reverse genetics and chemical approaches to assess the role of ES-localized GPCRs in the regulation of
B. malayi secretory function. In Aim 3, we will use whole-organism model nematode and mammalian single-cell
heterologous expression platforms to deﬁne the pharmacology of ES-localized GPCRs and to establish functional
assays for GPCR screening. Completion of this project will produce fundamental new knowledge about the ﬁlarial
nematode ES system and deliver new lead targets and validated screens for novel anti-ﬁlarial drug discovery.

Public health relevance
Project Narrative Lymphatic ﬁlariasis is a mosquito-transmitted nematode (roundworm) parasitic disease that infects millions of people worldwide, causing chronic disability and physical disﬁgurement. The goal of this research is to leverage technical advances we have made to (1) gain a better understanding of a parasite tissue system that is essential to how parasites communicate with and manipulate their hosts, and (2) to identify and proﬁle receptors within this system that can potentially be targeted to disrupt the establishment or maintenance of infection.